TASK C34: PILOT INFECTION MODEL IN PIG-TAILED MACAQUES: ASSESSMENT OF NEISSERIA GONORRHEA (GC) AND CHLAMYDIA TRACHOMATIS (CT) CO-INFECTION

This contract provides for the development and standardization of non-human primate models for infectious diseases, and may include efficacy testing of candidate products, including GLP studies to support licensure.